KDM5 histone lysine demethylases as potential novel myeloid tumor suppressors

ABSTRACT: KDM5 histone lysine demethylases as potential novel myeloid tumor suppressors.
Mutations in Isocitrate Dehydrogenase (IDH1 and IDH2) are present in over 20% of cases of de novo normal
karyotype AML and in 10-20% of cases of secondary AML that result from leukemic transformation of
myelodysplastic syndrome (MDS) or myeloproliferative neoplasm (MPN). Mutant IDH transforms cells by
producing R-2-hydroxyglutarate (R-2HG), an oncometabolite that can inhibit the activity of a number of cellular
enzymes, including TET2, a myeloid tumor suppressor that regulates the methylation state of DNA. It is not
known if R-2HG has other pathogenic targets besides TET2 in AML. However, the phenotypes of IDH mutant
and TET2 mutant myeloid diseases are quite different. This observation forms the basis of the premise of our
proposal, which is that inhibition of other pathways by R-2HG contributes to mutant IDH-mediated
transformation.
We performed an unbiased positive-selection CRISPR-Cas9 screen to identify novel tumor suppressors in
AML, and we identified two histone lysine demethylases, KDM5A and KDM5C, as potential pathogenic targets
of R-2HG in IDH mutant AML. Our central hypothesis is that KDM5A and KDM5C regulate hematopoietic stem
cell function, and that disruption of KDM5A and KDM5C activity by R-2HG contributes to mutant IDH-mediated
transformation. Our proposed studies address this hypothesis by asking three key questions. First, what is the
mechanism by which KDM5 loss promotes cytokine-independent proliferation of TF-1 cells, an
established factor-dependent human AML cell line? cDNA rescue experiments and genomic profiling of
histone lysine methylation and transcription will be used, in conjunction with genetic manipulation of KDM5
enzymes, to elucidate the unique and shared functions of KDM5 isoforms in AML. Second, what evidence is
there that KDM5 enzymes are inhibited by R-2HG in IDH mutant AML? We will profile the histone
methylation state of primary IDH mutant and IDH wild-type AML patient samples, and will characterize the
epigenetic and transcriptional states of isogenic cell lines that express wild-type and mutant IDH to determine if
inhibition of KDM5 enzymes by R-2HG contributes to the mutant IDH-mediated transformation. And finally,
how does loss of Kdm5a affect normal murine hematopoiesis and clonal hematopoiesis induced by
loss of canonical myeloid tumor suppressors? We will employ conditional Kdm5a knock-out mice to
perform detailed analyses of hematopoiesis in mice that lack Kdm5a alone and that lack Kdm5a in combination
with Dnmt3a, Nf1 or Tet2.
The answers to these questions will give us a greater understanding of the role of KDM5 demethylases in
normal and malignant hematopoiesis, and in IDH mutant AML in particular. This work is conceptually
innovative in that it will establish a novel epigenetic mechanism that contributes to AML, and is significant in
that it has the potential to lead to novel therapeutic approaches to treat patients with leukemia.

Public health relevance
Acute Myeloid Leukemia and other advanced clonal myeloid disorders have a high mortality rate despite aggressive multimodality treatment. Epigenetic pathways play an important role in the transformation of normal hematopoietic stem cells into acute myeloid leukemia. The goal of this study is to understand how one particular family of epigenetic enzymes, KDM5 histone lysine demethylases, contributes to leukemia. The results of this study will provide critical insights that will help to guide the development of more effective targeted therapies to treat acute myeloid leukemia and other clonal myeloid disorders.